PAST-DUE (Prevention and Social Determinants: Disparities and Utilization in Latino Elders)

Project Summary/Abstract
Americans aged 60 and over underutilize recommended preventive healthcare. Older
Latino-Americans underutilize preventive services to an even greater degree than non-Hispanic
whites, but the factors that drive this disparity most heavily are poorly understood. Some
evidence in the health services literature suggests that social determinants of health (individual-
and community-level economic, social, and environmental factors) affect utilization of preventive
health care. It is uncertain, however, which specific services may be most underused by older
Latinos, and which social determinants are most strongly associated with this group's utilization.
The dearth of knowledge about social determinants and preventive service utilization in
older Latinos is due, at least in part, to the lack of comprehensive data on ambulatory health
care utilization linked to data on individual- and community-level social determinants of health.
This project will assess disparities in preventive service use between older Latinos and older
non-Hispanic Whites, and identify the factors underlying those disparities. To do so, we will
leverage a unique data resource from a large, national network of community health centers
with shared electronic health record data that is linked to community-level social determinants of
health data. This large, longitudinal dataset contains unprecedented data linkages which will let
us assess disparities, evaluate which social determinants affect utilization and disparities, and
determine which of these may do so most significantly over time; in so doing, we will address an
important knowledge gap. Understanding the factors (individual or community) that most heavily
impact preventive service use is crucial to the prioritization of population-based interventions to
improve preventive screening.
Understanding the relative impact of social determinants of health on preventive service
use in older Latinos will enable action/intervention in three ways: 1. It will enable more informed
policy decisions to improve public health and wellness in older Americans. 2. It will facilitate
strategic partnerships between healthcare providers and community agencies poised to
intervene in social factors in the lives of older Americans. 3. It will help clinical providers
understand their patients' barriers to care utilization, and further point-of-care efforts to address
these barriers that influence their older patients' utilization of recommended health care
services.

Public health relevance
Project Narrative Many demographic and social factors affect the health of older Latinos in the United States, in part by impacting the use of recommended preventive health care. However, it is unknown which specific factors affect the use of specific preventive care in elders most significantly. This project will use a highly innovative, linked database that combines electronic health care data and community-level information to better understand which social factors most heavily affect the use of preventive care among Latino seniors.